The roles and mechanisms of inflammation resolution in the development of Rheumatoid Arthritis

Abstract/Summary
Rheumatoid arthritis (RA), a common autoimmune rheumatic condition, has no cure and even with novel
treatments, is associated with significant irreversible joint damage, physical disability, and numerous
comorbidities. The appearance of serum anti-citrullinated protein antibodies (ACPAs) indicates RA-related
autoimmunity and defines the start of the preclinical period of RA, which is the ideal time to identify relevant
disease risk biomarkers and approaches for disease prevention. The etiology of RA has a genetic component,
which may interact with environment in the development of disease. RA is characterized by excessive chronic
inflammation, suggesting a failure in the ability to control/resolve inflammation. Mechanisms for both initiating
and resolving inflammation are important for physiological homeostasis. Lipid mediators, products of the
metabolism of omega-3 and omega-6 polyunsaturated fatty acids, are involved in both initiation and resolution
of inflammation. We have shown that an elevated level of an individual omega-6 lipid mediator (5-HETE)
increased risk of progression from RA-related autoimmunity to inflammatory arthritis. However, as lipid
mediators share common pathways and enzymes, we propose that individual lipid mediators do not act in
isolation and therefore should be analyzed in combination as a profile. We propose to conduct a study in three
novel at-risk cohorts: the Targeting Immune Responses for Prevention of Rheumatoid Arthritis (TIP-RA) cohort
of 81 ACPA+ individuals, the Studies of the Etiologies of RA (SERA) cohort of 79 ACPA+ individuals, and the
StopRA cohort of 144 ACPA+ individuals in the preclinical period of RA that have been followed over time for
the development of RA. We will create lipid mediator profiles (a composite score of combinations of highly
correlated lipid mediators) indicating the ability to resolve inflammation by performing principal components
analysis of the lipid mediators and look at the trajectories of these profiles over time. Aim 1 will determine if the
association of these profiles with progression from ACPA+ to RA differs by genetic susceptibility to RA. We will
also explore whether the association is mediated by cytokine profiles or trajectories. Aim 2 will explore the
underlying mechanism by examining whether the lipid mediator profiles are associated with DNA methylation
differences or trajectories. Aim 3 will examine inflammation resolution in the lung by identifying sputum lipid
mediator profiles and cytokines associated with progression from RA-related autoimmunity to RA. Results from
this work will provide the foundation for designing prevention studies by elucidating which combinations of lipid
mediators play a role in inflammation resolution in preclinical RA. The inability to resolve inflammation can lead
to chronic inflammation; a common pathogenic element of RA. Elucidating mechanisms as well as the site (ie
lung) of inflammation resolution during the preclinical period of RA significantly contributes to the
understanding of pathogenesis and development of innovative interventions for RA.

Public health relevance
Project Narrative Rheumatoid arthritis (RA), one of the most common rheumatic conditions, is characterized by chronic inflammation. We will examine the role of lipid mediators (products of omega-3 and omega-6 fatty acids that are known to regulate inflammation) in the development of RA, focusing on the preclinical period prior to the onset of RA. Results from this work will provide the foundation for designing future prevention approaches and studies by identifying the combinations of lipid mediators that play a role in inflammation resolution in preclinical RA.